Regulatory T cell modulation of reactive astrogliosis in brain metastasis

Project Summary
The main goal of this grant proposal is to investigate the interaction between regulatory T (Treg) cells and
reactive astrogliosis in the context of brain metastatic disease, and their impact on the brain metastatic process.
Brain metastasis represents the final stage of cancer, for which very limited treatment is available. Inevitably,
patients with brain metastasis succumb to disease in a very short time. There is a strong resistance to the initial
development of brain metastasis, and the activation of astrocytes represents one of the earliest events observed
during the establishment of brain lesions. Their dual role first opposing and then favoring brain metastatic
progression has only started to be investigated. Treg cells colonize and expand in the inflamed brain tissue, and
have been shown to inhibit reactive gliosis in a model of stroke. We have demonstrated that Treg cell ablation
in early and late brain metastasis results in significant reduction of the brain tumor burden, and leads to extensive
expansion of reactive astrogliosis. In this research proposal, we use a combination of in vivo genetic modeling,
ex vivo brain organotypic slice cultures, immunohistochemistry, flow cytometry, and single cell RNASequencing
to investigate the hypothesis that Treg cells promote the establishment and progression of brain metastasis by
modulating the highly heterogenous and plastic reactive astrocyte population. Results from the proposed studies
will illuminate the mechanisms of brain metastatic disease, and will provide novel opportunities based on a largely
unexplored therapeutic niche.

Public health relevance
Project Narrative Brain metastasis represents the last stage of cancer, for which there are no therapies to date. We have found that ablation of regulatory T cells, which infiltrate primary tumors and metastasis and correlate with poor prognosis, strongly suppresses brain metastasis, and control reactive gliosis. A better understanding of the mechanisms controlling the cross talk among Treg cells, reactive astrocytes and tumor cells may lead to new approaches to combat this disease.